Sensory Coding in Taste

DESCRIPTION (provided by applicant): Ingestive decisions play a key role in a number of human conditions including obesity, diabetes, anorexia, hypertension, and coronary artery disease. The sense of taste is the most important factor in regulating these ingestive decisions, and therefore plays an important role in human health. Research conducted over the last few decades shows that taste centers in the brain have direct reciprocal connections with brain areas involved in homeostasis and ingestion. Taste has also been shown to engage the reward system, and dysfunction in this system may lead to overeating and obesity. However, the exact route whereby taste information engages reward and ingestive brain areas is unclear. The parabrachial nucleus (PBN) is a critical relay in the brainstem where gustatory information diverges via several ascending pathways to access forebrain sites involved in sensory discrimination, learning, intake and visceral processing, as well as reward. The studies of this proposal will test the hypotheses that a projection from the PBN to the ventral tegmental area (VTA) mediates taste-evoked reward, and a projection from the PBN to the lateral hypothalamus (LH) mediates taste-evoked ingestion. We will use a combination of complementary anatomical, physiological, and behavioral techniques to address this hypothesis. We propose the following specific aims: Aim 1: Functional organization of the gustatory PBN in mice. We will collect comprehensive normative data establish the organization of this key nucleus in wild type and taste-impaired mice. Aim 2: Does a direct projection from the PBN to the VTA mediate taste-evoked reward? This hypothesis will be first be evaluated with tract tracing and taste-evoked fos-like immunoreactivity (FLI) techniques: We will investigate whether or not VTA-projecting neurons are activated preferentially by sweet-tasting, rewarding stimuli in intact or taste-blind mice. We will also physiologically characterizing taste neurons that project to VTA using in vivo recording techniques. Finally, we will test the hypothesis that the VTA is essential for normal reward, but not taste function, by combining lesions of this area with behavioral analysis. In Aim 3, we will use a similar set of approaches to address the hypothesis that a direct projection from the PBN to the LH mediates taste-evoked ingestion, including tract tracing and taste-evoked FLI, in vivo physiology, and lesions of LH followed by measurement of behavior. We will utilize taste-blind trpm5 null mice in these experiments in order to separate effects of taste vs. post-ingestive feedback.

Public health relevance
PUBLIC HEALTH RELEVANCE: Ingestive decisions play a key role in a number of human conditions including obesity, diabetes, anorexia, hypertension, and coronary artery disease. The sense of taste is the most important factor in regulating these ingestive decisions, and therefore plays an important role in human health. The goal of this research is to elucidate pathways in the brain that link taste to feeding and reward. Ingestive decisions play a key role in a number of human conditions including obesity, diabetes, anorexia, hypertension, and coronary artery disease. The sense of taste is the most important factor in regulating these ingestive decisions, and therefore plays an important role in human health. The goal of this research is to elucidate pathways in the brain that link taste to feeding and reward. __SpecificAimsTextDelimiter__ Specific Aims Ingestive decisions play a key role in a number of human conditions including obesity, diabetes, anorexia, hypertension, and coronary artery disease. The sense of taste is the most critical factor in regulating these ingestive decisions, and therefore plays an important role in human health. This is not merely due to the location of taste receptors at the beginning of the alimentary canal; evidence accumulated over the last few decades shows that taste centers in the CNS have direct reciprocal connections with brain areas involved in homeostasis and ingestion (e.g. Yamamoto, 2006; Lundy, 2008). Taste and feeding both activate dopaminergic reward pathways in the brain. Engagement of these pathways is assumed to play an important role in overconsumption of foods and obesity. However, the route by which gustatory information engages reward centers is unclear. The parabrachial nucleus (PBN) is a pivotal relay in the brainstem where gustatory information diverges via several ascending pathways to access forebrain sites involved in gustatory discrimination, learning, intake and visceral processing, as well as reward. Our new data in the mouse reveals for the first time that PBN neurons project directly to the ventral tegmental area (VTA), a key reward area in the midbrain. These neurons, located in the gustatory portion of the PBN, are preferentially activated by orally delivered sucrose, a sweet-tasting, rewarding stimulus. Aim 1 of this proposal will functionally characterize the PBN in terms of gustatory organization in both wild type (WT) and taste-impaired Trpm5 knockout (KO) mice. Aim 2 tests the hypothesis that the PBN-VTA projection mediates gustatory-activated reward using complementary functional neuroanatomical, physiological, and lesion-behavior techniques. Aim 3 tests the hypothesis that a taste-activated projection from the PBN to the lateral hypothalamus (LH), an important feeding center, mediates taste-evoked ingestion. The same set of experimental techniques used in Aim 2 will be used to examine this hypothesis. We will use C57BL/6J (B6) and Trpm5 KO mice in all Aims; the Trpm5 null mice possess severe deficits in taste processing, but possess post-ingestive responses that are indistinguishable from wild-type mice. Results from B6 and KO mice will allow us to dissociate the effects of taste vs. visceral activation of the reward and ingestive pathways. Aim 1: The functional organization of the gustatory PBN in mice. We will achieve this characterization using the data collected in Aims 2 and 3. We will examine the cytoarchitectural organization of the PBN, and projection pattern, in B6 and KO mice. We will construct three-dimensional maps of basic taste quality representation in the mouse PBN, using both taste-elicited c-Fos-like immunoreactivity (FLI) and in vivo single unit recording techniques. This will provide comprehensive normative data on the functional organization of the PBN in both B6 and KO mice. Aim 2: Does a direct projection from the PBN to the VTA mediate taste-evoked reward? Three experiments will test this main hypothesis: Experiments 2A and 2B will test the hypothesis that sweet- tasting (i.e. rewarding) stimuli preferentially activate this projection. In Experiment 2A we will examine taste- elicited c-fos-like immunoreactivity (FLI) in VTA-projection neurons, and in Experiment 2B we will examine the physiological taste profile of neurons that project to the VTA. Experiment 2C will test the hypothesis that the VTA is essential for normal reward, but not taste function, by combining dopaminergic lesions of this area with taste, reward and ingestive behavior measures. These experiments will be conducted in B6 and KO mice, in order to separate effects of taste vs. post-oral feedback. Aim 3: Does a direct projection from the PBN to the LH mediate taste-evoked ingestion? Experiments 3A and 3B will test the hypothesis that appetitive stimuli such as sweet and umami compounds preferentially activate LH-projecting taste neurons. This will be accomplished using taste-elicited FLI in concert with retrograde tracing (Exp. 3A), and with extracellular recordings of LH-projecting taste neurons (Exp. 3B). Experiment 3C will examine the role of the LH in taste and ingestive behaviors by excitotoxic lesions of this area with the same suite of behaviors measured in Experiment 2C. These experiments will be conducted in B6 and KO mice, in order to separate effects of taste vs. post-oral feedback.